A Novel Mechanism of Action Natural Product for Treatment of Drug-Resistant Gonorrhea

Project Summary/Abstract:
This project seeks to develop a new class of antibiotics against Neisseria gonorrhoeae (NG). NG is considered
to be of the highest threat level by the CDC due to its propensity to rapidly develop drug resistance. CFD
Research has discovered a novel natural product (NP) with potent NG activity, which we seek to develop here.
Aim 1 will build on our established medicinal chemistry program to diversify and optimize the NP’s scaffold for
improved potency, cytotoxicity and drug-like properties. Aim 2 will test the in vivo efficacy of the best analogues
from Aim 1 in an established mouse model of NG infection. During Phase II, these data will drive further
medicinal chemistry design and synthesis of a lead series. Mechanism of action will be elucidated. Followed by
in vivo toxicity, and pharmacokinetics to produce an optimized lead compound for further preclinical
development as a novel NG antibiotic.

Public health relevance
Project Narrative: The goal of this project is to develop our novel natural product into a new class of antibiotics to combat drug-resistant Neisseria gonorrhoeae infections.